A Low-Cost, Portable Guidance System for Needle Biopsy

DESCRIPTION (provided by applicant): Early disease detection through percutaneous needle biopsies is considered the gold standard for cancer diagnoses and thus for obtaining good health outcomes. This project seeks to ameliorate health disparities by making it possible for general practitioners and other health professionals to perform image-guided needle biopsies in their own office or clinic rather than sending patients with suspect lesions to distant centers. Th key enabling technology is an ultrasound-based guidance system designed to provide intuitive and reliable in-situ guidance that can be used by interventionalists with minimal training, allowing doctors to perform needle biopsies on patients in their own clinic or office. The project consists of three aims. The first aim will develop and evaluate an easy-to-use guidance system for targeted needle biopsy by focusing on the development of the guidance platform itself, including device construction, internal calibration, interfaces to the ultrasound system, and the development of several guidance modes. The second aim will extend guidance system with registration between pre-operative CT and ultrasound foriImage-guided interventions, by providing new algorithms for ultrasound- and surface- to CT registration, making it possible for expert annotations of critical structures to be transferred to the guidance system directly. The third aim will evaluate the system on phantom models and in a pilot animal study by practitioners of varying skill and training levels, and comparing it to state-of-the-art guidance systems. The third aim includes the creation of a health disparity advisory board to guide the further development of the device for deployment to reduce health disparities in rural and underserved populations.

Public health relevance
PUBLIC HEALTH RELEVANCE: Project Narrative Application title: A Low-Cost, Portable Guidance System for Needle Biopsy Funding Opportunity Announcement number: RFA-EB-12-001 The development of a low-cost, portable guidance system for needle biopsy will reduce health disparities by giving primary care personnel the ability to do diagnostic testing for cancer and liver disease staging in the primary care office or mobile unit. By producing a guidance system that is simple to use for less experienced medical personnel, and by making it cheap enough for small clinics to be able to afford, this technology reduces diagnostic health disparities created by the geographic, ethnic or economic differences which can limit access to care. __SpecificAimsTextDelimiter__ SPECIFIC AIMS Application title: A Low-Cost, Portable Guidance System for Needle Biopsy Funding Opportunity Announcement number: RFA-EB-12-001 Early disease detection through percutaneous needle biopsies is considered the gold standard for cancer diagnoses and thus for obtaining good health outcomes. This proposal seeks to ameliorate health disparities by making it possible for general practitioners and other health professionals to perform image-guided needle biopsies in their own office or clinic rather than sending patients with suspect lesions to distant centers. The medical device in this proposal utilizes an innovative technology to make ultrasound-guided needle biopsies available at a price that is affordable even in the smallest office. Moreover, the guidance mechanism can be used by interventionalists with minimal training, allowing doctors to perform needle biopsies on patients in their own clinic or office. The specific objective of our Phase I effort is to establish the feasibility and usability of a simple, low-cost portable handheld device to enable image-guided percutaneous interventions such as ablative therapies and biopsy procedures, which will substantially increase access of underserved populations to these interventions. Our innovation is based on the integration of light imaging (cameras) and projection capabilities directly on an ultrasound probe. These components replace the cumbersome and costly external tracking systems that are now coming onto the market from several other vendors. Based on this hardware platform, we are proposing to develop a software system that provides an intuitive, easy to use, and cost-effective guidance system that will increase access to needle biopsy specifically, and needle-based procedures more generally. We propose a two year plan of work based on two specific aims: Aim 1: Develop and Evaluate and Easy-to-Use Guidance System for Targeted Needle Biopsy In this aim, we will focus on developing a basic guidance capability that provide feedback showing the final target position of the needle relative to the patient in the ultrasound image, or, conversely, the preferred location and angle of needle insertion to reach a specific target indicated in the ultrasound image. These capabilities and the overall usability of the system will be evaluated on phantom models. Aim 2: Extend Guidance System with Registration between Pre-operative CT and Ultrasound for Image- Guided Interventions In this aim, we will extend the basic guidance system of Aim 1 to include targeting based on registration with diagnostic CT imaging. This will allow the clinician to transfer a target indicated by e.g. an expert radiologist at a remote site to the live ultrasound image, and to use the available guidance methods to achieve this target. Aim 3: Evaluate System on Phantom Models and in a Pilot Animal Study In this aim, we will perform a series of system evaluations on phantom and in-vivo animal models at a series of checkpoints. The evaluation will be performed by users with a variety of skill levels to provide insights into the usability of the system as well as the quantitative accuracy and reliability of its function. Our work during Phase I will be in close collaboration with physicians who work with underserved populations in urban Baltimore. In Phase II, we expect to expand our network to include rural clinics in under- served areas, and to evaluate a pre-market prototype within that network.